Select Series Cyclic IMS Mass Spectrometry System

PROJECT SUMMARY
We request funds to purchase a high-resolution and high-sensitivity liquid chromatography-mass
spectrometry system for the analysis of small molecules and biomolecules at the University of
Colorado Boulder (CU-Boulder) as well as other research institutions in Colorado. The proposed
instrument consists of a Waters SELECT SERIES Cyclic Ion Mobility QTOF (SS-cIMS) mass
spectrometer, a Waters ACQUITY Premier UPLC, and a Waters ACQUITY HDX Manager UPLC.
It will be housed in the Central Analytical Laboratory (CAL), which is the mass spectrometry
service core facility at CU-Boulder. It will be used to support mass spectrometry needs for
measuring small molecule high-resolution accurate mass, biomolecule mass including intact
protein mass analysis, peptide LC-MS/MS and mapping of post-translational modifications, and
hydrogen-deuterium exchange mass spectrometry (HDX-MS). This new instrument is needed to
replace an existing Waters Synapt G2 system that is now 15 years old and in poor condition.
Importantly, Waters Corp. will soon end service support for the Synapt G2 on December 31, 2024.
Therefore, we have an urgent need to replace the Synapt G2 with a newer QTOF instrument that
can fill the critical needs in synthetic chemistry and biomolecular analysis that is prevalent across
our research community. In addition, the proposed instrument would enable the CAL facility to
expand its research capabilities, by enabling new experiments using ion mobility mass
spectrometry and native mass spectrometry to evaluate chemical and conformational
heterogeneity of large macromolecular complexes. These will synergize and support emerging
research among our large community of structural biology researchers at CU-Boulder, who are
using single particle cryo-electron microscopy and cryo-electron tomography to determine
structures of large complexes at atomic resolution.

Public health relevance
PROJECT NARRATIVE We request funds to purchase a state-of-the-art mass spectrometry system, consisting of a Waters SELECT SERIES Cyclic IMS QTOF mass spectrometer, an ACQUITY Premier UPLC, and a HDX Manager UPLC. This instrument will replace an existing instrument that is a workhorse for analyzing small molecules and biomolecules for NIH-funded research labs. The instrument is urgently needed, because service on our current system will end in December 2024, after which it will no longer be supported by the vendor.